The Impact of Myosin-Binding Protein C on Myosin Mobility and Proteostasis.

Hypertrophic cardiomyopathy (HCM) is frequently caused by mutations in the MYBPC3 gene, which lead to
reduced levels of myosin-binding protein C (MyBP-C). MyBP-C is a key protein in myosin-based thick filaments
within cardiac muscle sarcomeres. Reduced levels of MyBP-C are proposed to disrupt normal heart structure by
effecting the function of myosin, leading to hypercontractility. While the FDA-approved drug mavacamten
(Camzyos) targets the function of myosin, it does not compensate for MyBP-C's other known role in muscle
contraction, including its interactions with actin-based thin filaments, or emerging roles in the maintenance of
thick filament structure. This gap raises concerns about the efficacy of mavacamten, particularly for patients with
MYBPC3-related HCM. Innovative techniques now allow for deeper investigation into the mechanisms by which
reduced levels of MyBP-C result in HCM. Early findings suggest that the absence of MyBP-C in MyBP-C
knockout (KO) mouse hearts is energetically costly due to enhance myosin replacement through synthesis and
degradation. In addition, the absence of MyBP-C reduces the dynamic exchange of myosin molecules between
thick filaments and a pool of soluble monomers within the sarcomere and limits the contractile function of the
myocardium. These insights allow for a novel hypothesis that MYBPC3-related HCM results from dysregulation
in myosin proteostasis, involving reduces myosin dynamics and contractile function. Such a hypothesis has not
been previously explored in any HCM models. In addition, research into MyBP-C has primarily focused on its N-
terminal regions, but new data show the C-terminal domains may play a critical role in modulating each of these
processes. Understanding these mechanisms could reveal new aspects as to how MyBP-C' contributions to
heart health. Clinically, although mavacamten shows promise for the treatment of HCM due to mutations in
myosin itself, preliminary data from MyBP-C KO mice indicate that mavacamten has limited efficacy in restoring
myosin proteostasis, mobility, or contractile due to the loss of MyBP-C. This suggests that mavacamten may not
be optimal for these patients. This supports the need for a more personalized treatment, like gene therapy to
restore full-length MyBP-C expression. This study utilizes advanced technologies to closely replicate whole-heart
physiology, including stable isotope labeling, adeno-associated viral (AAV)-induced protein labeling, quantitative
mass spectrometry, multiphoton imaging, and cardiac tissue slice mechanics. These methods are applied to
transgenic mouse models that mimic human hypertrophic cardiomyopathy (HCM). The results will enhance our
understanding of the complex interplay between myosin proteostasis, dynamics and contractility in HCM and will
provide data that helps guide future, more tailored treatments for MYBPC3-related HCM.

Public health relevance
PROJECT NARRATIVE Cardiac muscle myosin molecules are organized within large macromolecular complexes, yet recent data suggest that individual molecules are quickly exchanged within these complexes to maintain cellular balance. Preliminary findings indicate that myosin-binding protein C (MyBP-C) plays a crucial role in regulating this exchange, and its absence in hypertrophic cardiomyopathy disrupts complex stability and contractile function. This project aims to uncover the mechanisms by which MyBP-C governs these processes and to evaluate the impact of two distinct therapeutic approaches in correcting these dysfunctions.